Optical gearbox enabled high-speed multiphoton microscope

ABSTRACT
Neurological disorders affect millions of people each year, many with no cures. Researchers and clinicians are
actively seeking a deeper understanding of how the human brain functions to develop new treatments and cures.
Optical functional imaging is a tool broadly applied in neuroscience. The advance of genetically encoded
functional indicators allows the visualization of neuronal activities with light in the living brain. Currently, laser
scanning two-photon fluorescence microscopy (TPM) remains the most widely employed solution for deep
imaging in the mammalian brain. Current TPM is too slow to keep up with neuronal signals which are transmitted
and processed on the millisecond time scale. Although some high-speed imaging methods exist, their complexity,
tradeoff, and cost have prevented adoption and broad utilization by most labs. There is an unmet market need
for a simple and easy-to-use high-speed TPM imaging system. Photomatrix, an Indiana-based small business,
was formed to commercialize emerging technology from Purdue University (Meng Cui, PI) based on previous
NIH-funded research. Photomatrix’s optical gearbox, an add-on unit to existing laser scanning microscopes, can
flexibly change the scan rate and field-of-view (FOV) by adjusting the gear ratio. To develop the technology for
the commercial neuroscience market, the team will develop an optical gearbox-based TPM with robust
performance, compact design, and user-friendly interface. Phase I efforts will focus on demonstrating the
feasibility of the technology with the following Aims. 1: Develop a preliminary prototype of a compact optical
gearbox for high-speed TPM with a 200 kHz line rate. The gearbox-based TPM must be compact and robust to
meet customer needs. The team will construct a compact and solid system of long-term stability with a footprint
of less than 2’x3’ and a maximum line scan rate of ~200 kHz for fast purely linear scanning. 2: Integrate gearbox
with ultra-large etendue detection for superior imaging depth and quality. Using preliminary data, the team will
integrate the gearbox with this ultra-large etendue detection for superior imaging depth and quality to achieve at
least a 300% increase in signal strength for deep tissue imaging. 3: Develop the FPGA-based data acquisition
system and basic user interface (UI) functions. Photomatrix must develop an integrated Field Programmable
Gate Arrays (FGPA) based data acquisition system to fully control the system with a single device. The UI will
resemble ScanImage software in functionality and appearance but will offer much-improved imaging speeds. At
the end of Phase I, Photomatrix will have a prototype high-speed TPM system with ~200 kHz line rate,
demonstrated superior deep tissue imaging performance, and a fully functional UI. Phase II will focus on
converting the prototype system into a commercially viable solution with a full software package that can be
easily adopted in the field and sold to research labs across the globe. Photomatrix is targeting the adoption of
100 systems in the first three years of commercialization and up to 500 within 10 years with a current market
size exceeding $210M.

Public health relevance
NARRATIVE Neurological disorders affect millions of people each year, many with no cures. To better understand neurological disorders, researchers use optical functional imaging to visualize neuronal activities with light in the living brain. However, most current tools are too slow to keep up with neuronal signals which are transmitted and processed in the brain on the millisecond time scale. Although some high-speed imaging methods exist, their complexity, tradeoff, and cost have prevented adoption and broad utilization by most labs. This STTR focuses on developing a simple and easy-to-use high-speed TPM imaging system for use in neuroscience and biology labs.